Iowa Food Protection Rapid Response Team

Iowa Food Protection Rapid Response Team Project Summary/Abstract Summary of Proposed Activity: The Iowa Department of Inspections and Appeals (DIA), the Iowa Department of Public Health (IDPH), the Iowa Department of Agriculture (IDALS), and the State Hygienic Laboratory at the University of Iowa (SHL) will work collaboratively with FDA to develop and implement a Iowa Rapid Response Team (RRT) for large scale food and feed emergencies. The Iowa RRT will have the combined expertise and resources of multiple agencies leading to a multidisciplinary approach that facilitates a coordinated, efficient, and effective response. Statement of Objectives and Methods to be Employed Two key groups will compose and support the Iowa Rapid Response Team program, the RRT Coordinating Council and the Core Rapid Response Team Members. The RRT Coordinating Council will serve as an advisory group to the Core RRT Members. The second key group is the Core RRT Members, which consists of three members, a Rapid Response Team Coordinator, the RRT Public Health Liaison and a RRT IDALS Liaison. The Core RRT Members will meet weekly to accomplish the activities outlined on the Milestones Table included in this cooperative agreement application. The RRT Coordinating Council will meet monthly with the Core RRT Members to assess progress, identify obstacles, and provide assistance as appropriate. The RRT Coordinating Council and Core RRT Members will hold quarterly meetings with federal partners including the FDA and USDA FSIS in order to review progress and identify resource needs for further RRT program development and implementation. Broad, Long Tem Objectives The Iowa RRT will develop an all-hazards food and feed protection program in collaboration with other RRTs and the FDA. The mission of the Iowa RRT will be to effectively respond to foodborne outbreaks and identify potential preventive practices to protect the food supply and consumer health nationally and globally.

Public health relevance
Project Narrative The Iowa RRT will develop an all-hazards food and feed protection program in collaboration with other RRTs and the FDA. The mission of the Iowa RRT will be to effectively respond to foodborne outbreaks and identify potential preventive practices to protect the food supply and consumer health nationally and globally. __SpecificAimsTextDelimiter__ Iowa Food Protection Rapid Response Team Specific Aims Iowa is a mid-sized state, smaller in population than all of the current rapid response team states. As such, Iowa has the potential to be a leader in scaling the rapid response program and its concepts for smaller, more agriculturally-based states. Iowa is also somewhat unique in the number and varied nature of natural disasters occurring within our state; since 1953 there have been 48 major disaster declarations made for Iowa by the Federal Emergency Management Agency. In the last several years, large scale flooding events have impacted several of our more densely populated communities including Des Moines, Cedar Rapids, and Council Bluffs. There are many food and feed related industries operating within these communities. Given the local, statewide, national, and global impacts of Iowa's food manufacturing and agricultural industries, providing prompt and high quality response to food /feed emergencies, including foodborne illness complaints, is critical. The development of an Iowa Rapid Response Team will help to ensure that our state is ready to respond to these emergencies. Given the local, statewide, national, and global impacts of Iowa's food manufacturing and agricultural industries, providing prompt and high quality response to food /feed emergencies, including foodborne illness complaints, is critical. Specific objectives and outcomes of the Iowa RRT • Develop an Iowa RRT • Develop policies and procedures related to food and feed emergency response • Train Iowa RRT members and the investigation team • Exercise the developed policies and procedures and update as lessons are learned • Implement an after action process for all actual events and exercises • Develop a data system to facilitate the sharing of food complaint and incident information • Improve proficiency of food and feed emergency response • Increase communication and collaboration between federal, state and local response partners • Develop a sustainable RRT concept that will continue after the cooperative agreement funding ends • Contribute to national guidance and best practices for food and feed emergency response Iowa has a strong history of working collaboratively across agencies on food and feed related issues. Development of an Iowa RRT will strengthen and build upon these existing relationships.